Metabolically Reprogramming Hepatic Macrophages to Conquer Immune Desert Tumors

PROJECT SUMMARY/ABSTRACT
Tumors with different oncogenic mutations display diverse immunophenotypes that can affect CD8+ cytotoxic T
lymphocyte (CTL)-mediated cancer immunosurveillance. Specifically, b-catenin activation leads to an “immune-
desert” tumor microenvironment due to impairment of type 1 dendritic cell (DC1)-mediated CD8+ T cell priming,
with mutations in the CTNNB1 gene among the most frequent oncogenic events in human hepatocellular
carcinomas (HCCs). Of note, hepatic macrophages (hMfs) reside within a unique intra-vascular tissue niche
with potential to act as antigen-presenting cells (APCs) to prime naïve T cells. Following our recent findings that
monocyte-derived tumor-associated macrophages (TAMs) are capable of cross-presenting cancer cell antigens
to CD8+ T cells and activation of the metabolic regulator mechanistic target of rapamycin complex 1 (mTORC1)
potently affects macrophage differentiation and function, we will herein explore the effect of mTORC1 signaling
on hMf APC functions in a murine model of b-catenin-driven HCC. Our preliminary data showed that hMfs
lacking the mTORC1 suppressor TSC1 could correct the CD8+ T cell priming defects in the “immune-desert”
HCC model and restore cancer immunity. Furthermore, TSC1-deficient hMfs display enhanced mitochondrial
activities with the malate-aspartate shuttle playing a critical role to support macrophage reprogramming. Based
on these observations, we hypothesize that hMfs can be reprogrammed via TSC1 deletion to overcome the
“immune-desert” phenotype of b-catenin-driven HCC by acting as effective APCs to prime and activate CD8+ T
cells, and this capability relies on their metabolic reprogramming. To test this hypothesis, I propose the following
specific aims: 1) To determine whether and how TSC1-deficient TIM4- hMfs function as APCs to promote CD8+
T cell-mediated cancer immunity; 2) To define whether and how TSC1-deficient TIM4- hMfs are metabolically
programmed to support CD8+ T cell-mediated cancer immunity. Completion of this project will generate
mechanistic insights into the fundamental question of metabolic control of macrophage functions in cancer, and
provide a novel therapeutic strategy to overcome immune evasion caused by defective DC-mediated T cell
priming in “immune-desert” tumors. My long-term career goal is to become an independent investigator and lead
a laboratory studying the metabolic function and mechanisms of tumor macrophages. To achieve this goal, I
have devised a detailed career plan to gain skills in leadership, management, mentorship, grant writing, and
scientific communication. I will work under the mentorship of Dr. Ming Li, a leader in the fields of cancer
immunology and immunometabolism. Additionally, I have assembled an advisory committee comprised of Drs.
Lionel Ivashkiv, Amaia Lujambio, Andrea Schietinger, and Hongbo Chi to provide me with complementary
expertise and guidance in both scientific and career development. My research and career development plan,
combined with the guidance of my mentor and advisors, as well as the outstanding academic environment at
MSKCC, will serve as the bedrock for my independence in the field of tumor macrophage research.

Public health relevance
PROJECT NARRATIVE Antigen-presenting cells (APCs) play a crucial role in initiating and activating cytotoxic immune cells to target and eliminate cancer cells. However, “immune-desert” tumors, which lack sufficient APC infiltration, often exhibit reduced cytotoxic immune cell activity. This research project aims to address this challenge by metabolically reprogramming hepatic macrophages, turning them into highly effective APCs to suppress tumor progression via boosting cancer immunosurveillance. These investigations hold the potential to introduce innovative strategies for turning “cold” tumors into “hot” tumors, offering new hope in the fight against cancer.